Expanding the design space of protein-small molecule conjugates

PROJECT SUMMARY/ABSTRACT
Targeted therapy and targeted drug delivery have revolutionized clinical care of complex disease whenever
these options are available – and, yet, only a minority of patients have access to these precision medicine
approaches where their care is based on the molecular basis of their disease. Such molecular targeting leads
to better patient outcomes and fewer toxic side effects compared to traditional treatment approaches, for a range
of diseases. As part of expanding precision medicine to all patients with complex diseases, there is a critical
need to meet the molecular targeting gaps in clinical care where such options currently do not exist. Protein-
drug conjugates have immense promise in targeted therapy and drug delivery applications, with a number of
recent successes in the form of antibody-drug conjugates (ADCs) for cancer therapy. However, numerous design
challenges for protein-drug conjugates remain, including narrow therapeutic windows and difficulty in translating
success in oncology to other clinical indications. Even within oncology, solid tumors remain significantly more
difficult to treat than hematological cancers. Our hypothesis is that the current set of modular components in the
design space is limiting and leads to many of the current challenges. Therefore, there is an unmet need to create
and validate protein-drug conjugate components and combinations beyond those currently being used. The
overall goal of this proposed research is to expand the design space for protein-drug conjugates, enabling this
class of molecules to have further success in a wider range of applications in biotechnology and medicine. We
propose to validate scaffold proteins and side-chain reactive polymers as modular components for novel
protein-drug conjugate structures. As a model protein scaffold for this work, we will use the Fn3 polypeptide
fold, which has been demonstrated to be extremely versatile for engineering molecular recognition using rational
and directed evolution approaches. We propose to modify model Fn3 proteins with canonical and non-canonical
amino acids to enable site-specific bioconjugation reactions (Aim 1). As a novel linker system for protein-drug
conjugates, we propose to use side-chain reactive poly(PFPA), as a model polymer for synthesizing protein-
polymer-drug conjugates. Side-chain reactive polymers are more chemically versatile than current linkers in use
for ADCs, and can serve multiple functions to overcome current ADC limitations. We will functionalize polymer
poly(PFPA) to enable conjugation to specific protein sites, and load releasable small molecules onto the polymer,
using a range of drug loading ratios, with combinations of small molecules to enable combination therapy (Aim
2). We will measure and model cellular and tissue trafficking of the conjugates (Aim 3), a key consideration for
therapeutic success. The overall objective of this application is to extend the capacity of scaffold proteins and
side-chain reactive polymers to fill the gap in molecular targeting challenges. Our work will have a broader
positive impact by establishing methods for synthesizing bioconjugates using a myriad of polypeptide folds and
polymer linkers, towards the ultimate goal of creating targeted treatments for every patient who needs them.

Public health relevance
PROJECT NARRATIVE The overall goal of this work is to make the care of complex diseases more effective and less toxic. This research will develop molecules that can be used for targeted drug delivery, improving outcomes and reducing side effects of current therapies. This research specifically looks at developing a molecular platform that can be applied to a wide range of diseases, such as immunological disorders, cancer, and neurological disease.